Substrate Specificity Determinants in Nutrient Solute Carrier Transporters

SUMMARY
In humans, there are over 460 Solute Carrier (SLC) transporters that mediate the import and efflux of solutes,
including neurotransmitters, nutrients, and ions. The SLCs are emerging as key therapeutic targets for a variety
of diseases and disorders. For example, nutrient SLC transporters play a major role in reprogrammed metabolic
networks in cancer, autoimmune disease, and heart ischemia, by supplying cells with nutrients that are used to
build biomass or serve as signaling molecules that enhance cell proliferation and differentiation, or regulate cell
death. Our broad goal is to describe the substrate and inhibitor specificity determinants in nutrient
transporters and develop novel strategies to modulate their functions. We take an integrative approach
that includes computational biology and organic chemistry, coupled with biochemical and biophysical
approaches, and in vitro models of disease, to characterize the Alanine-Serine-Cysteine Transporter 2 (ASCT2,
SLC1A5).
In Aim 1 of this project, we will generate and refine homology models for the human SLC1 family in multiple
conformations. We will describe structural features of the models’ substrate binding site and recently discovered
allosteric site(s), that determine substrate and inhibitor specificity. Key residues will be tested with site-directed
mutagenesis and electrophysiological approaches. Finally, we will develop a publicly-accessible database that
includes homology models for all modelable human SLC transporters, and maps disease-related mutations onto
the models and provides their predicted functional effect.
In Aim 2, we will rationally design small molecule tool compounds that modulate the function of nutrient
transporters via distinct mechanisms. This will expand the chemical space of transporter inhibitors and provide
a test for the models developed in Aim 1. We will focus on the following approaches: (A) optimizing and
characterizing novel conformation-specific inhibitors, such as photoactivatable and fluorescent compounds that
interact with the substrate binding site of ASCT2; (B) designing allosteric inhibitors targeting the domain-domain
interface in ASCT2, to test the putative elevator mechanism of this transporter; and (C) developing inhibitors with
dual specificity for ASCT2 and the L-type Amino Acid Transporter 1 (LAT1, SLC7A5), which we hypothesize to
have a pronounced inhibitory effect on cell proliferation due to their cooperativity in reprogrammed metabolic
networks.
If successful, this project will improve our understanding of structure-function relationships in emerging
therapeutic targets. This project will also provide novel chemical probes to further characterize the structure of
these proteins and their role in disease, as well as a useful publicly available online resource.

Public health relevance
NARRATIVE Solute Carrier (SLC) transporters mediate the transport of ions, nutrients, drugs, and toxins, across biological membranes, and play a key role in hyper-proliferative cells, by supporting the increased reliance on glutamine. Our broad goal is to elucidate the mechanisms of transport and chemical modulation of SLC nutrient transporters, by using an integrated experimental and computational approach. This work will allow us to develop computational and chemical tools to study emerging therapeutic targets, characterize structure/function relationships in understudied proteins, and ultimately, provide a unique strategy to deprive nutrients and starve malignant cells, greatly benefitting human health.